Inflammatory regulation of epileptogenesis after status epilepticus

PROJECT SUMMARY
As the second most common neurological emergency, status epilepticus (SE) is a group of life-threatening
conditions that are characterized by hypersynchronous epileptic activity that lasts for five minutes or longer
without full return of consciousness, and the overall SE-associated mortality rate in adults is about 20-30%.
The generalized convulsive SE constitutes about 45-74% of all cases and has long been known to trigger
neuronal damage, and patients who survive SE can develop long-term neurological sequelae. As such, SE
triggers changes in the brain that can lead to lifelong epilepsy and overall increases the risk of epilepsy by
more than three times compared to non-SE seizures. Despite an increasing list of US FDA-approved
antiseizure drugs (ASDs), about 23-43% of SE patients will progress to refractory SE and do not satisfactorily
respond to current medications, and the mortality rates in these patients can approach up to 39%. Current
ASDs are also well known for their broad neurotoxic adverse effects that are often unbearable and can further
complicate the management of seizures. It is another unfortunate fact that these medications only provide
symptomatic relief and have not been shown to prevent the development of epilepsy after de novo SE or
modify the progression of seizures. Development of the prevention and/or modification strategies for post-SE
epilepsy must hinge on a good understanding of signaling pathways that are provoked by SE and in turn
trigger epileptogenic processes, such as brain cytokine surge, reactive gliosis, neuronal damage, blood-brain
barrier disruption, and brain infiltration of leukocytes and blood proteins, which eventually accumulate in the
occurrence of unprovoked seizures, i.e., chronic epilepsy. Previous studies by us and others show that the
prostaglandin E2 (PGE2) receptor EP2 plays essential roles in brain inflammation, neuronal damage, and
behavioral deficits after SE in rodents. Our results from the previous grant cycle also reveal that Gαs-coupled
EP2 regulates microglial activation to release cytokines via its downstream effector – exchange protein
activated by cAMP (EPAC), and the SE-upregulated EPAC in turn contributes to neuroinflammation. Objective
of this proposed study is to reveal the molecular and cellular mechanisms whereby PGE2/EP2/EPAC axis
triggers these neuroinflammatory processes after SE and thus contributes to acquired epilepsy and behavioral
comorbidities. To achieve this goal, we will use multiple in vitro (aim 1) and in vivo (aims 2 and 3) models
engaging a unique set of genetic and pharmacological approaches that we developed during the previous
funding cycle. Completion of this study will provide novel insights into the regulation of neuroinflammatory
processes in the epileptogenesis after de novo SE, which should be also relevant to epilepsies triggered by
other brain insults, such as strokes, TBIs, brain infections and tumors, owing to the shared commonalities in
epileptogenic processes. If successful, this work will have identified new targets for disease modification and/or
prevention of epilepsy and could guide the drug development for novel antiepileptogenic pharmacotherapies.

Public health relevance
RELEVANCE Despite the growing list of new antiseizure drugs, status epilepticus remains the second most common life- threatening neurological emergency and triggers a series of neuropathological changes in survivals that can lead to lifelong epilepsy. Current medications merely provide symptomatic relief and are not effective in > 30% of patients, not to mention the unbearable side effects. The proposed research will uncover neuroinflammatory signaling that is essential to the development of spontaneous seizures, and thus might provide novel druggable targets to prevent epilepsy or modify its progression after status epileptics and other precipitating brain insults.